The role of T cells in tendon healing

PROJECT SUMMARY
Tendon injury is a common problem characterized by slow recovery and high recurrence. Improving
tendon healing to a functionally effective state is therefore a crucial research priority, however the basic
biological mechanisms remain unknown. Our overall objective is therefore to identify the cellular and
molecular events that distinguish healing mechanisms to improve adult tendon healing.
One key feature in all wound healing is the immune environment. Injury initially induces an inflammatory
type 1 response, followed by transition to an anti-inflammatory type 2 response. Imbalanced type 1 or
type 2 responses are often associated with fibrotic healing or degeneration. To date, T cells have
rarely been investigated, even though T cell subpopulations regulate type 1 and type 2 immune
responses, macrophage polarization, and in some cases can directly active tissue-resident stem cells. Due
to this gap in research, the mechanisms by which specific immune cell populations create
permissive environments for effective and poor healing are not known, especially for poor healing
tissues such as tendon.
We previously established novel models of effective tendon healing (neonatal mouse) and
fibrosis (adult mouse), and identified cellular mechanisms that distinguish these. Based on rigorous pilot data,
we now hypothesize that T cell subpopulations mediate tendon healing through direct and indirect
interactions with tenocytes and by mediating effective tendon healing or chronic inflammation via IL33-
dependent mechanisms. To test these hypotheses, we will define the role of neonatal vs adult T cell
populations and T cell-tenocyte interactions after tendon injury (Aim 1), elucidate the mechanisms of Treg-
mediated resolution of IL33 in tendon healing (Aim 2), and determine the pathological consequences of
chronic IL33 inflammation in tendon healing (Aim 3)

Public health relevance
Project Narrative Tendon ruptures and tendinopathies are painful and debilitating conditions affecting a large portion of the adult population. From a regenerative standpoint, there is a pressing clinical need to identify the cell and molecular mechanisms regulating tendon differentiation vs fibrotic scarring in order to improve repair outcomes. Since the local immune environment and T cells are implicated in both effective and poor tendon healing, the objective of the proposed studies is to fully define the T cell subpopulations underlying tendon healing and to test the role of IL33.